DREAMS - Translational Research Core - Health Equity & Action Translational (HEAT)

Project Summary/Abstract: Health Equity & Action Translational (HEAT) Research Core
There is growing recognition that, in order to promote health equity across the diabetes continuum, a new
generation of translational research must address system and policy level drivers of inequities. As one of two
translational research cores within the Diabetes Research for Equity through Advanced Multilevel Science
Center for Diabetes Translational Research (DREAMS-CDTR), the new HEAT (Health Equity & Action
Translational) Research Core, we will employ a multi-level systems approach to designing action-oriented,
rigorous observational and interventional research address health disparities and promoted health equity in the
greater San Francisco Bay Area and the Central Valley. The Core is motivated by the need to: a) design and
optimized targeting and tailoring of diabetes-related interventions and public health policy to promote health
equity and reduce inequalities, and b) to monitor the impact of innovations in care delivery, public health and
social policy on existing health inequalities.
We aim to build capacity in carrying out translational research that addresses the range of systems that
generate or undermine health – from clinical healthcare systems to public health systems to social systems.
Expanding in this way is aligned with the recognition that achieving health equity in diabetes not only will
require new ways of delivering care in diverse health systems, but also new ways to influence and transform a
range of systems within and outside of healthcare so as to affect the so-called ‘structural determinants of
health.’ This goal will be accomplished by 1.) Maintaining and deepening a vibrant and collaborative cross-
disciplinary research environment, 2.) Supporting junior investigators, 3.) Disseminating findings among the
scientific community and with key stakeholders, including the communities most affected by diabetes, and 4.)
Providing timely, authoritative and tailored consultation to a range of stakeholders, including investigators, local
health system leaders, community-based organizations, and regional public health, social service and social
policy entities on disparities-related topics.